The role of FSP27b on dietary lipid absorption, lipoprotein secretion, and oxidative metabolism

SUMMARY
The proposed work will define the role of the lipid droplet-associated protein CIDEC (also known as FSP27) on
the metabolic fate of lipids in liver and intestine, circulating lipoproteins, and oxidative lipid metabolism in muscle
and brown adipose tissue (BAT). Dysregulation of lipid metabolism is the basis of some of the most common
medical disorders in Western populations, such as cardiovascular disease, hyperlipidemia, fatty liver diseases,
obesity, and insulin resistance. The long-term goal in our laboratory is to elucidate molecular and cellular
mechanisms governing whole-body lipid homeostasis, both under physiological and pathological conditions.
CIDEC/FSP27 encodes 2 isoforms, a and b, with strict tissue distribution. Here we will exploit Fsp27bKO mice to
reveal the role of FSP27b (the sole FSP27 expressed in liver and intestine, and the major isoform in BAT) on
the partitioning of lipids for storage/oxidation/secretion. We will test the new ideas that FSP27b is a critical
regulator of hepatic APOB lipidation and secretion, dietary lipid absorption and postprandial lipemia, and fatty
acid utilization in peripheral tissues. The proposed studies will be transformative for our understanding of: i)
mechanisms governing the biogenesis and secretion of pro-atherogenic lipoproteins; ii) lipid biology in major
oxidative tissues; and iii) metabolic cross-talk between liver and other tissues, an area that has been largely
neglected in the past.
To achieve the goal of defining the role of FSP27b on lipid metabolism, we plan three specific aims. Aim 1 will
test the hypothesis that FSP27b promotes the lipidation and secretion of APOB-containing lipoproteins in liver
and intestine. Aim 2 will test the hypothesis that hepatic FSP27b limits the availability of PPAR agonists for
peripheral tissues. Aim 3 will test the hypothesis that FSP27b reduces energy expenditure in brown adipose
tissue.
Importantly, some of the proposed research will correct the published scientific record on FSP27, which is based
on a flawed “Fsp27-floxed” mice. The translational relevance of our studies is highlighted by reports showing
that polymorphisms in FSP27 are associated with elevated fasting triglyceridemia in humans, and that loss-of-
function mutations result in familial partial lipodystrophy, type 5 (FPLD5). Overall, success of the proposed
studies will fill a large gap of knowledge in whole-body lipid (patho)physiology, by defining molecular mechanisms
of lipid droplet-mediated control of triglyceride metabolism in liver, intestine, muscle, and brown adipose tissue,
with particular attention to multi-organ metabolic cross-talk via circulating lipids. These studies may also establish
FSP27 as a valid pharmacological target to manage fatty liver diseases, diet-induced obesity, dyslipidemias, and
cardiovascular risk in patients.

Public health relevance
PROJECT NARRATIVE Polymorphisms in the gene encoding the lipid droplet-associated protein FSP27 are associated to elevated fasting lipids in blood, and loss-of-function mutations in FSP27 lead to FPLD5 (familial partial lipodystrophy, type 5). The proposed studies will define the molecular mechanisms of FSP27-mediated control of lipid metabolism in liver, intestine, muscle, and brown adipose tissue, with particular attention being paid to metabolic cross-talk among these tissues via lipoproteins and liver-synthetized bioactive lipids. The results from these studies will serve a two-fold purpose: they will amend the scientific record on FSP27 which is based on inadequate mouse models, and they may lead to novel and improved ways to manage patients with lipid-related disorders that include dyslipidemia, fatty liver disease, obesity, and cardiovascular disease.